Phase I/II trial of green tea and quercetin in docetaxel chemotherapy

Project Summary/Abstract
The long-term goal of this study is to develop a highly effective non-toxic regimen by a combination of natural
products green tea (GT) and quercetin (Q) to enhance the therapeutic effect of docetaxel (Doc) in treatment of
metastatic and castration-resistant prostate cancer (mCRPC) in African-American (AA) patients. The risk of
advanced prostate cancer including mCRPC in AA men is 2.5 fold greater vs. Caucasians, and the increased
risk can not be eliminated by corrections for factors that may affect the access to health care. This emphasizes
the importance of improving the clinical treatment of prostate cancer in order to reduce the disparity in prostate
cancer mortality. Doc is a standard treatment for mCRPC. However, severe dose limiting toxicities along with
chemoresistance limit the clinical success of Doc. The resistance to Doc is associated with upregulation of
anti-apoptotic signaling and overexpression of transport proteins including MRP. Previously we found that Q
can synergistically enhance the anti-cancer effect of GT in prostate tumor cells by increasing bioavailability of
non-methylated GT polyphenols, increasing pro-apoptotic signaling and decreasing MRP1 expression.
Therefore, GT and Q may be ideal candidates to be combined with Doc to sensitize tumor cells to Doc. Our in
vitro studies demonstrated that combining GT and Q with Doc synergistically enhanced the anti-proliferative
effect in CRPC cell lines. The combined effect of GT/Q/Doc was further confirmed in our animal studies,
where GT and Q enhanced the potency of Doc 2-fold in inhibition of PC-3 xenograft tumor growth, with no
increased toxicity. The objective of the proposed phase I/II trial is to assess the efficacy and safety of GT and
Q in combination with Doc for mCRPC in AA patients. Specific aim 1 will evaluate the safety and efficacy of GT
and Q in combination with Doc in AA patients with enzalutamide- or abiraterone- resistant mCRPC. Aim 1a will
determine the recommended phase II dose (RP2D) of GT and Q with Doc/prednisone. A phase I-II trial with the
EffTox design will be carried out to test three dose levels with 8 cohort of patients (n=3 per cohort). The
selection of optimal doses for successive patient cohorts will be based on both efficacy and toxicity. Aim 1b
will assess the efficacy of GT and Q with Doc/prednisone compared to Doc/prednisone. An extended phase II
study will be conducted with the enrollment of additional patients on RP2D and a control group, with 30
patients for each group. Specific aim 2 will validate the effect of GT+Q in reversing the resistance to Doc in
prostate cancer mouse models. Two different mouse models will be utilized, including a xenograft model of
Doc-resistant PC-3 tumors and a prostate-specific PTEN knockout mouse model with a Doc-resistant tumor
phenotype. The proposed study will set the stage for phase III clinical trials of this highly promising and
urgently needed regimen to enhance the treatment of mCRPC and reduce disparities in PCa mortality in AA
patients. Given the non-toxic nature of both GT and Q this study could deliver near term benefit to patients.

Public health relevance
Project Narrative The proposed project is anticipated to provide a highly effective novel regimen to enhance current treatment of advanced prostate cancer by using two natural products to synergize with chemotherapy drug, in order to reduce disparities in prostate cancer mortality in African-American patients. The combination of these natural compounds will provide additional benefits to patients in treatment of side effects associated with drug therapy.